Regulation of Exosome Secretion as a novel therapeutic approach for Alzheimer's Disease

Project abstract
Current available treatments for Alzheimer's disease (AD) only provide modest amelioration of cognitive
and behavioral decline. Recent clinical trials targeting amyloid-β (Aβ) production or clearance did not show
efficacy prompting a reexamination of approaches to AD treatment. Brains from AD patients have been
shown to exhibit accumulation of ceramide, a signaling molecule and an integral component of exosomal
membranes. One major source of ceramide is through the hydrolysis of sphingomyelin catalyzed by neutral
sphingomyelinase 2 (nSmase2). Even though transient increases in ceramide through nSMase2
upregulation are part of normal brain functioning, experimental evidence indicates that chronic nSMase2
upregulation results in negative effects including neuroinflammation and oxidative stress. Recent studies
also implicate nSMase2 in both Aβ aggregation and tau protein propagation through exosome secretion
from neurons and glial cells. Moreover, inhibition of exosome synthesis by genetic or pharmacological
inhibition of nSMAse2 significantly reduced Aβ aggregation and tau propagation both in vitro and in vivo
thus opening a new avenue for AD therapeutics. While nSmase2 is emerging as an important player in AD
etiology, the current armamentarium of nSMase2 inhibitors is inadequate to develop potential treatments.
Currently available inhibitors have limitations including low potency (IC50's in µM level), poor solubility, and
limited brain penetration. In order to address these limitations, we developed a human nSMase2 high
throughput screening assay and screened over 350,000 compounds which led to the identification of
several hits belonging to different chemical series. Early optimization of two of these hits from different
chemical series led to two potent compounds with IC50s of 50 and 300 nM. Both of these compounds were
confirmed as inhibitors of exosome release and exhibited good pharmacokinetic profiles and brain
penetration (AUCbrain/AUCplasma = 0.27 and 0.6). The objective of this proposal is to further optimize these
nSMase2 inhibitors to identify a potent, selective, brain penetrable candidate to carry out proof of concept
before future IND enablement studies and ultimately for treatment of patients with AD. Aim 1 is to conduct
structure-activity relationship studies to improve potency. Aim 2 is to characterize the compounds from aim
1 for functional inhibition of exosome release, metabolic stability, selectivity and in vivo pharmacokinetics.
Aim 3 is to carry out in vivo proof of concept studies by evaluating selected compounds in the 3xTg mouse
model of AD. The work proposed involves a novel therapeutic target which is mechanistically distinct from
previous efforts in AD treatment, has the potential of addressing disease progression, and exploits two
newly discovered chemical series of drug-like nSMase2 inhibitors.

Public health relevance
Project Narrative Pharmacological and genetic evidence in three distinct Alzheimer's disease (AD) mouse models suggests that the enzyme neutral sphingomyelinase 2 (nSMase2), through regulation of exosome release, plays a significant role in both amyloid-β and tau propagation, which are hallmarks of the disease. Currently there are no drug- like nSMase2 inhibitors available; the goal of this proposal is to optimize two independent chemical series of drug-like nSMase2 inhibitors recently identified by high throughput screening to bring to IND enabling studies. NSMase2 is a novel therapeutic target that is mechanistically distinct from prior efforts in AD treatment with the potential of addressing disease progression.